Enhancing Alzheimer's-related research in rural South Africa with portable MRI

PROJECT SUMMARY
This project will incorporate portable, low-field brain magnetic resonance imaging (MRI) into a population-
representative study of Alzheimer’s disease (AD) and related dementias (ADRD) in rural South Africa,
transforming the ability to assess ADRD-related brain atrophy and cerebrovascular disease in low- and middle-
income country (LMIC) settings. Increasing incidence and prevalence of ADRD represent a global health crisis
that disproportionately affects LMICs, including South Africa. The study of ADRD risk, pathogenesis, and course
has been revolutionized by the development of accessible fluidic biomarkers that capture the amyloid and tau
components of AD-related pathophysiology, but direct measurement of neurodegeneration and cerebrovascular
disease - - primary drivers of cognitive outcomes and clinical progression - - is limited in rural areas and LMICs
because of the cost, infrastructure, technological access, and expertise required to conduct MRI research. Newly
developed portable MRI scanners coupled with advances in data post-processing now provide the possibility to
conduct high-fidelity, high-throughput brain imaging studies in rural settings. The proposed study will enhance
the research infrastructure and resources for studies of ADRD neuroscience relevant to Africa by being the first
to establish and incorporate portable brain MRI for the study of ADRD in rural South Africa. The proposed work
leverages the robust infrastructure, cohort, and resources available through the Health, Aging and Dementia in
South Africa: A Longitudinal Study (HAALSI; P01 AG041710), an ongoing population-representative study that
addresses core issues in dementia epidemiology in older South Africans. HAALSI has completed three waves
of longitudinal dementia survey data in over 5,000 participants over aged 40 within a population-representative
cohort in Agincourt (“HAALSI Agincourt”). Two additional waves of intensive dementia data collection have been
completed under the Harmonized Cognitive Assessment Protocol (HCAP) among more than 600 HAALSI
participants over age 50 (“HAALSI Agincourt-HCAP”; R01 AG054066). Over 300 structural MRI scans at 1.5T
field strength have been acquired in these participants. During the UG3 phase of the proposed study, we will
install a low-field portable MRI scanner in a community health facility in Agincourt; establish acquisition, data
transfer, and analytic pipelines; and collect portable MRI data among 350 Agincourt-HCAP participants with
available 1.5T MRI scans, biomarker, and clinical data. During the UH3 phase, we will conduct the largest
portable MRI ADRD study in a LMIC to date, acquiring 3500 MRI scans (including 300 repeat scans) in HAALSI
Agincourt participants to examine associations of atrophy and cerebrovascular disease with ADRD fluidic
biomarkers, cognition, vascular factors, and social determinants. Consistent with RFA-AG-24-027, we will
transform collaborations between US and African scientists; enhance research infrastructure and resources to
study ADRD in South Africa; and conduct preliminary studies that will inform future ADRD research in Africa.

Public health relevance
PROJECT NARRATIVE Increasing incidence and prevalence of Alzheimer’s disease and related disorders (ADRD) represent a global health crisis that disproportionately affects low- and middle-income countries (LMICs), including South Africa. The study of ADRD risk, pathogenesis, and course has been revolutionized by the development of accessible fluidic biomarkers that capture the amyloid and tau components of AD-related changes, but direct measurement of neurodegeneration and cerebrovascular disease - - primary drivers of cognitive outcomes and clinical progression - - is limited in rural areas and LMICs because of the cost, infrastructure, technological access, and expertise required to conduct magnetic resonance imaging (MRI) research. The proposed study will transform the research infrastructure and resources for studies of ADRD neuroscience relevant to Africa by being the first to establish and incorporate portable, low-field brain MRI for the study of ADRD in rural South Africa.